Central RAAS and Brain Small Vessel Disease

Although the consequences of small vessel disease (SVD) are devastating for brain, there are no specific
therapies at present. Knowledge of mechanisms that underlie and might potentially be used to prevent SVD
and its effects, which include strokes and cognitive deficits, is very limited. Brain parenchymal arterioles are
important resistance vessels and preferential targets of SVD. Hypertension is a the leading risk factor for
SVD. For reasons that are not clear, hypertension is a greater risk factor for stroke than for myocardial
infarction. Although the brain renin-angiotensin-aldosterone system (RAAS) contributes to hypertension, it is
not known if it also affects the local vasculature. In that sense, cerebral vessels may be subjected to both
increased intravascular pressure as well as local effects during activation of the brain RAAS. Our overall
hypothesis is that the cerebral circulation is affected by the central RAAS and that endothelial peroxisome
proliferator-activated receptor-γ (PPARγ) protects against such effects. We propose two Specific Aims. Aim
1 uses two models to determine if activation of the brain RAAS affects function, structure, or mechanics of
cerebral arteries and parenchymal arterioles. One is a recent variation of the DOCA-salt model,
characterized by activation of the brain RAAS, but suppression of the peripheral RAAS. In the second, the
brain RAAS is activated by genetic manipulation. Preliminary data suggest the central RAAS impacts select
signaling pathways, vasomotor regulation, and vascular structure. Interestingly, these effects were specific
for cerebral vessels. Aim 2 will determine if endothelial PPARγ protects against central RAAS-induced
vascular changes via mechanisms that include suppression of angiotensin II receptors, oxidative stress, and
the ROCK2 isoform of Rho kinase. Pilot data support this Aim as well. The premise for these studies fit well
within the goals of this RFA, focusing on novel mechanisms that underlie SVD during hypertension. The
models exhibit features making them representative of a greater percentage of people with essential
hypertension compared to more common approaches. Pilot data reveal vascular heterogeneity that
contributes to increased susceptability of the brain circulation during hypertension. In summary, the impact
of SVD is great, but our understanding of the underlying vascular biology and the impact of hypertension on
the brain vasculature in lacking. Using innovative models and approaches, the proposed work will fill gaps
identified in the literature and by the scientific community regarding needed advances in our understanding
of SVD, vascular biology, and impact of hypertension on the brain vasculature. This area of study has
unquestionable relevance to global health. Our sharing of expertise and resources supports a focus on
mechanisms of SVD with models and approaches and concepts that are unique.

Public health relevance
Small vessel disease (SVD) in brain is a key cause of stroke and a major contributor to cognitive deficits and other neurological diseases. Although hypertension is the greatest risk factor for stroke and a leading cause of SVD, there are no specific therapies at present. Knowledge of mechanisms that underlie and might potentially be used to prevent SVD is very limited. Our overall hypothesis is that the cerebral circulation is affected by the local brain renin-angiotensin system and that specific endothelial-based mechanisms protect against these effects. We focus on a unique and critically important segment of the vasculature where surprisingly little is known using innovative models and approaches.